Better utilization of omics data to inform precision medicine for asthma throughout the life course

PROJECT SUMMARY
Asthma exacerbations are a major cause of disease morbidity and lead to progressive loss of lung function,
airway remodeling, and enhanced disease severity. Their associated economic burden is substantial, totaling
approximately 15 million outpatient visits, 2 million emergency room visits, and 500,000 hospitalizations each
year in the United States alone. Predisposition to asthma exacerbations is influenced by genetics and triggered
by environmental exposures that result in a dysregulated immune response. Viral and bacterial infections are
the leading risk factors for asthma exacerbations. While a few virulent species have been well-studied, a
comprehensive assessment across a range of viral and bacterial stimuli, as well as their interactions with multiple
omics, to understand how these are linked to individual susceptibility has not been performed. Recent
technological advances in Phage ImmunoPrecipitation Sequencing (PhIP-Seq) have facilitated a high-
throughput, cost-effective evaluation of global virulent exposures, enabling for the first the estimation of
cumulative exposures in the context of asthma exacerbations. As such, our overarching objective is to identify
the impact of prior viral, bacterial, and other virulent exposures on asthma exacerbations and severity by
employing PhIP-Seq profiling coupled with multiple omics (genetics, epigenetics, and metabolomics). Our overall
hypothesis is viral and bacterial exposures interact with host genetics and downstream omics differentially across
individuals; these relationships are relevant to disease exacerbations and will differ across the life course. We
will first characterize lifetime virulent exposures through PhIP-Seq profiling, then identify exposures and multi-
omic variants associated with asthma exacerbations- as well as interactions between these complementary omic
layers- and finally, construct universal and personalized predictive models of the impact of these exposures on
asthma severity through a cooperative learning methodological approach. We will leverage four well-
characterized child and adult asthma cohorts, totaling 4,000 individuals, with existing genetic, epigenetic, and
metabolomic data, and apply novel approaches to data integration. The demographic diversity of these cohorts
allows us to interrogate both life course effects, as well as sex as a biological variable and differences by race
and ethnicity. These results hold unprecedented potential to enlighten the complex relationships between
virulent exposures, omic profiles, and asthma exacerbations, providing novel avenues for more personalized
therapeutic targets and management strategies.

Public health relevance
PROJECT NARRATIVE Exposure to viral and bacterial infections represents a leading risk factor in asthma exacerbations, but individual variability in response, and the role of multi-omics in this response, is not well-understood, particularly across the life course. Characterization of virulent exposures through PhIP-Seq profiling in well-characterized child and adult asthma cohorts with existing genetic, epigenetic, and metabolomic data provides an ideal opportunity to leverage novel integrative omic methods, specifically cooperative learning, to increase our understanding of the impact of these virulent exposures, their interactions with individual biology reflected by multi-omics, and their consequences for asthma exacerbations. We apply PhIP-Seq in existing cohorts with minimal cost to this proposal, identify virulent and multi-omic factors with the highest contributions to asthma exacerbations, and develop universal and personalized predictive models to understand the interplay between these factors and to assess risk with respect to individual variability.